Discovery and Development of Organic Reactions Catalyzed by Transition Metals Valuable for Medicinal Chemistry

Project Summary/Abstract
This diversity supplement will support the training of a first-generation Cuban-American Ph.D.
candidate conducting research under the topics of the parent grant. This student will investigate
the formation of carbon-heteroatom bonds at sp3 sites by allylic substitution and C-H bond
functionalization. In one line of investigation, catalysts will be designed based on cationic
allyliridium intermediates in enantioselective, catalytic allylic substitution process that will broaden
the reaction scope to enable substitutions that form tertiary carbinamines from allylic alcohol
derivatives. In a second line of investigation the candidate will conduct studies to extend the scope
of iron-catalyzed azidation reactions, based on recent mechanistic findings, to achieve mild, direct
aminations of C-H bonds to form Boc-protected amines. As part of these research activities, the
candidate will follow a multi-pronged individualized training plan that includes participation in
tutorials in catalysis, mechanistic analysis and synthetic strategies conducted within our research
group, participation in group workshops on the writing of research grants, concerted guidance by
the mentor on the preparation of early manuscript drafts, and - building on a strength of the
candidate’s oral presentation skills - attendance of national meetings to present results with time
spent during preparation to learn advanced aspects of public presentations.

Public health relevance
Project Summary/Abstract To help build a diverse group of scientists addressing human health with a skill set in synthetic organic chemistry, this diversity supplement will support the training of Cuban-American Ph.D. candidate Ph.D. candidate conducting research under the topics of the parent grant focused on the development of synthetic methods relevant to the preparation of pharmaceutical candidates.